Mechanisms and metabolic implications of LRP130 in NAFLD

DESCRIPTION (provided by applicant): Non-alcoholic fatty liver disease (NAFLD) is the leading cause of liver disease in the United States. It spans a clinical spectrum from fatty liver to superimposed inflammation called NASH (non-alcoholic steatohepatitis). NASH predisposes to irreversible cirrhosis and hepatocellular carcinoma, which highlights the need to identify underlying mechanisms. In NAFLD, defective mitochondria liberate excess reactive oxygen species (ROS). Mitochondrial ROS is of interest, because it is implicated in insulin resistance and inflammation, two key features of NAFLD. The mechanism for mitochondrial dysfunction is unknown; hence, understanding its mechanistic basis may mitigate NAFLD. Our preliminary data indicate that LRP130 is an important regulator of mitochondrial function and ROS. In NAFLD, we observed that LRP130 is attenuated in a disease specific manner. Notably, depletion of LRP130 in mouse liver induced insulin resistance and inflammation. Mechanistically, LRP130 regulates the entire mitochondrial genome. Notably, LRP130 profoundly influences respiratory chain formation, respiration and superoxide formation. We hypothesize that LRP130 is a molecular link between defective mitochondria in liver and progression of NAFLD. We propose three Aims to query our hypothesis: (1) Evaluate the role of LRP130 in mitochondrial function and superoxide formation. The impact of LRP130 on mitochondrial bioenergetics will be evaluated using loss- and gain-of-function models in cells and mice. We will evaluate respiratory chain supercomplexes using blue native gel electrophoresis. Mitochondrial function will be measured by oxygen consumption, complex activity, membrane potential and superoxide measurements. (2) Evaluate the role of LRP130 in non-alcoholic fatty liver disease. Fatty liver will be induced by challenging mice with a high fat diet. Mice deficient for LRP130 in liver will be evaluated for insulin sensitivity and inflammation using a complement of assays: hyperinsulinemic-euglycemic clamp, immunodetection of insulin signaling, histological evaluation of inflammation and cytokine profiling. Parallel studies will be conducted with a liver specific LRP130 transgenic model. (3) Evaluate transcriptional and inflammatory control of LRP130. We hypothesize that cytokines attenuate transcription of LRP130, and may link cytokines to defective mitochondria and excess superoxide. We will use genetic studies, reporter assays and chromatin immunoprecipitation to test this hypothesis. Therapeutic manipulation of ROS in NAFLD is impeded by an insufficient understanding of basic mechanisms. Our novel findings on LRP130 will advance new paradigms on the role of mitochondria in NAFLD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity predisposes to heart disease, diabetes and fatty liver disease. Accumulation of fat in the liver may accelerate the development of heart disease and diabetes; hence, altering liver fat may be of therapeutic benefit. This proposal will investigate the role of a gene called LRP130 in fatty liver disease, and may provide new ways to treat diabetes and heart disease. Project Narrative Obesity predisposes to heart disease, diabetes and fatty liver disease. Accumulation of fat in the liver may accelerate the development of heart disease and diabetes; hence, altering liver fat may be of therapeutic benefit. This proposal will investigate the role of a gene called LRP130 in fatty liver disease, and may provide new ways to treat diabetes and heart disease. __SpecificAimsTextDelimiter__ Specific Aims Non-alcoholic fatty liver disease (NAFLD) is the leading cause of liver disease in the United States. Its increasing prevalence is driven by an epidemic of obesity and type 2 diabetes. NAFLD spans a clinical spectrum from fatty liver to superimposed inflammation called non-alcoholic steatohepatitis (NASH). Once NASH ensues, irreversible cirrhosis and hepatocellular carcinoma may develop. This underscores the need to identify causal factors important in disease progression. ROS (reactive oxygen species) derived from mitochondrial superoxide is of interest, because it is implicated in two key components of NAFLD and NASH; namely, insulin resistance, which worsens hepatic lipid accumulation, and hepatic inflammation, which worsens NASH. Defective mitochondria constitute a major source of excess superoxide; however, the mechanism responsible for mitochondrial dysfunction is unknown. Defects in the respiratory chain are considered to be important. Our preliminary data indicate that LRP130 is an important regulator of mitochondrial function and ROS. In human subjects with NAFLD, we observed that LRP130 is attenuated in a disease specific manner. Similar results were noted in a mouse model of NASH. Mechanistically, depletion of LRP130 in cells and mouse liver led to global suppression of respiratory components encoded by mitochondrial DNA (mtDNA). Concomitantly, respiration was decreased, while superoxide was increased. Conversely, ectopic expression of LRP130 induced the entire mtDNA program, enhanced cellular respiration, and reduced superoxide formation. Finally, depletion of LRP130 in mouse liver induced insulin resistance and incited hepatic inflammation. Our data suggests that perturbations in LRP130 dictate mitochondrial superoxide, an important precipitant of insulin resistance and inflammation in NAFLD. We hypothesize that LRP130 is a molecular link between defective liver mitochondria and progression of NAFLD. Specifically, we propose to: 1. Evaluate the role of LRP130 in mitochondrial function and superoxide formation. We will test the hypothesis that LRP130 controls mitochondrial function and superoxide formation by regulating mitochondrial encoded genes. LRP130 will be manipulated using viral vectors in gain- and loss-of function studies. In cells and mouse liver, respiratory chain assembly will be quantified using blue native gel electrophoresis and electron microscopy. Mitochondrial function will be assessed by three parameters: oxygen consumption, membrane potential and superoxide formation. 2. Evaluate the role of LRP130 in non-alcoholic fatty liver disease. We will test the hypothesis that LRP130 dictates hepatic inflammation and insulin resistance in NAFLD. First, LRP130 will be depleted in mouse liver using shRNA. Adeno-associated virus will be used to target shRNA to mouse liver. Fatty liver will be induced by feeding mice a high fat diet. We predict less LRP130 will incite inflammation and insulin resistance by increasing mitochondrial ROS. Second, we will determine if LRP130 is sufficient to retard insulin resistance and inflammation, using a liver specific LRP130 transgenic mouse model. Insulin resistance will be assessed by hyperinsulinemic-euglycemic clamp, insulin signaling by standard immunodetection, and inflammation by liver histology and cytokine profiling. 3. Evaluate transcriptional and inflammatory control of LRP130. Cytokines have been implicated in mitochondrial dysfunction and superoxide production. The mechanism for this phenomenon remains obscure. We will query the hypothesis that cytokines attenuate LRP130, which may mechanistically link cytokines to mitochondrial dysfunction and superoxide formation. Using a complement of genetic, reporter and chromatin immunoprecipitation studies we will study basic transcriptional control of LRP130 and how it is modulated by inflammatory cytokines. Therapeutic manipulation of ROS in NAFLD is impeded by an insufficient understanding of basic mechanisms. Our novel findings on LRP130 will advance new paradigms on the role of mitochondria in NAFLD.